Adipose tissue mediates cardiac metabolic remodeling in the pathologically stressed heart in the absence of primary metabolic stress

Project Summary:
The pathogenesis of heart failure is linked to systemic metabolic dysfunction, a comorbidity likely involving
peripheral organs, and resulting in insulin resistance in patients with and without diabetes. This study focuses
on the reciprocal response of adipose tissue to pathological stress on the heart and will investigate how
adipose tissue activity affects cardiac metabolic remodeling. This proposal originates from novel findings by
each of the MPI laboratories. We have identified transient changes in adipose tissue plasticity during the
pathogenesis of decompensated cardiac hypertrophy in response to pathological stress alone, absent any
primary metabolic stress, such as diabetes, nutrient overload, or obesity. This finding and our unpublished data
implicate cardiac natriuretic peptides (NP) as mediators of adipose activation and show that NPs are induced
by a reduction in long chain fatty acid (LCFA) oxidation by the heart, even without pathological stress.
Preliminary data reveal a profound, sex-specific array of early responses in white (WAT) and brown (BAT)
adipose tissue activity to cardiac pressure overload that include beiging of WAT and induction of a lipolytic
phenotype with cold exposure. While the cardiac responses to pathological stress include maladaptive
remodeling of lipid metabolism, the effects of adipose plasticity on the cardiac lipid profile during the
development of pathological hypertrophy are virtually unexplored. Thus, we hypothesize that: 1) the
metabolic response of reduced fatty acid oxidation in the heart during pathological stress induces plasticity of
WAT that is mediated by cardiac NPs in a sex-specific manner, distinct from β-adrenergic stimulation, with
downstream effects on glucose tolerance; and 2) sustained beiging of WAT and activation of BAT confer
cardioprotection against adverse cardiac metabolic remodeling. The research design supports three specific
aims: 1. Elucidate effects of adipocyte adrenergic activation on WAT beiging, and responses of cardiac LCFA
metabolism during TAC with adipose adrenergic activation and inhibition; 2. Determine whether adipose
plasticity results from NP effects in direct response to TAC or from the metabolic shift of reduced LCFA
oxidation in male and female mice; 3. Investigate a potential cardioprotective role of adipose browning on the
lipid profile of failing hearts. The overall objectives are to: 1) determine the reciprocal metabolic responses
between the pathologically stressed heart and adipose tissue via cardiac NP production and adipokine/lipokine
release (namely 12,13-diHOME), respectively; 2) elucidate the consequences of sex differences in the
responses of adipose tissue and myocardium to cardiac stress; and 3) explore the potential for WAT beiging or
BAT activation to provide cardioprotection via metabolic signaling. The findings will contribute new insights into
the adipose responses and contributions to metabolic remodeling of the heart during the pathogenesis of
decompensated cardiac hypertrophy, with the potential to identify targets for remediating the progression to
overt heart failure and improving peripheral and systemic metabolic dysfunction.

Public health relevance
Project Narrative The proposed study will determine how pathological stress on the heart induces metabolic adjustments to both the heart and adipose tissue, and how these reciprocal responses mediates both cardiac metabolic remodeling and the development of decompensated cardiac hypertrophy with potential consequences to systemic metabolism. We will first test the role of cardiac natriuretic peptide responses to altered cardiac fat oxidation as an activator of adipose tissue plasticity, independent of adrenergic activation of adipose tissue, and second, examine the potential for a cardioprotective role of the beiging of white adipose tissue and brown adipose tissue activation.